Microbiota-immune interactions that promote intestinal homeostasis

ABSTRACT
Individuals with inflammatory bowel disease (IBD) are more likely to develop metabolic abnormalities, such as
diabetes, however little is known about the basis of this connection. Multiple studies have now shown that
changes to the composition of the microbiota are a factor in multiple diseases, including IBD and diabetes.
Moreover, the studies that have examined the composition of the microbiota within individuals with IBD or
diabetes, have identified similar changes to these resident communities. We have recently identified a mouse
model that develops worsened colitis and spontaneous obesity and insulin resistance. Both of these diseases
are reliant on the microbiota and can be rescued by a microbiota transplant, or an oral gavage of a purified
population of Clostridia. Thus, we hypothesize that the growing incidence of IBD and diabetes may be
attributable to similar defects in the microbiota and might explain the why some individuals are more prone to
develop both diseases. Based on this, we propose a series of experiments to identify a defined consortia of
Clostridia that will function to prevent disease and explore the common mechanisms, including effects of the
immune system, between IBD and metabolism that might lead to the development of these diseases. Thus, our
findings will be among the first to identify a consortia of bacteria that could be used for therapeutic
intervention/prevention of IBD and/or diabetes and allow for an in-depth mechanistic understanding of how
these protective bacteria maintain intestinal homeostasis.

Public health relevance
PROJECT NARRATIVE Extra-intestinal manifestations, including insulin resistance, lipid abnormalities and diabetes can occur in 25- 40% of IBD patients, suggesting a link between metabolic defects and chronic intestinal inflammation. Here will test a role for a specific subset of commensal bacteria that might underlie the connection between these diseases.